Community Health and Neuropathy: Nutritional and Environmental Links in Zambia (CHANNELZ)

Project Summary/Abstract
The overarching goals of this project are to advance knowledge of the complex pathophysiology of distal
symmetric polyneuropathies (DSP) and frame future interventions for nutritional neuropathies in Zambia through:
1) assessment of population-based estimates and risk factors for DSP in Zambia’s maize and cassava staple
food zones; 2) comparison of population-based estimates and risk factors to previous clinic-based data from the
same maize-staple districts; 3) and assessing the odds of specific micronutrient deficiencies among DSP cases
and age, gender, and HIV-matched controls from the same districts. To accomplish these goals, Dr. Kvalsund
will focus on acquisition of additional expertise and experience in the following key areas: 1) advanced
epidemiological methods and analysis; 2) clinical trials methodologies, 3) global health policy; 4) neuropathy
outcome assessments; and 5) HIV and nutrition. The needed skills will be achieved through structured
mentorship, coursework, and pragmatic clinical trials and health policy experiences. The research-training plan
will provide Dr. Kvalsund with the additional proficiency necessary to undertake future intervention research
aimed at reducing nutrition-associated neurologic morbidity in Zambia and advancing scientific knowledge of the
pathophysiologic mechanisms that generate DSP as a common phenotype. The central hypothesis is that the
high rate of DSP previously observed in clinic populations in Zambia is equally prevalent outside healthcare
settings owing to common endemic infectious diseases and their neurotoxic treatments, food insecurity and low
dietary diversity, recurrent nutritional challenges, specific micronutrient deficiencies and their interactions, and
possibly other unidentified latent factors. We hypothesize that folate-deficiency will be highly associated with
DSP in Zambian communities, as has been documented in clinic populations, and may warrant a targeted public
health intervention given the preventable nature and range of other neurologic morbidities also associated with
folate deficiencies. The specific aims are to: 1) Determine population-based DSP estimates in Zambia; 2)
Compare and contrast DSP estimates and risk factors with those from clinical settings in Zambia; 3) to consider
the relative contributions of urbanicity, agroecological/staple food zone, and specific micronutrient deficiencies
on DSP prevalence; and 4) Evaluate for latent environmental or toxico-dietary factors as contributors to DSP in
this environment. The research is expected to provide the foundation for future R-01 intervention and
observational research and to improve scientific understanding of how diverse etiologies, multiple exposures
and interactions lead to a common clinicopathologic DSP phenotype, which remains poorly understood to date.

Public health relevance
Project Narrative Distal Symmetric Polyneuropathies (DSP) are highly prevalent among clinic populations in Zambia compared to other world regions and preventable nutritional and other treatable comorbidities are suspected to be contributing. Our study is designed to identify clinic- versus population-based risk factors for DSP in this setting. These studies will help define appropriate intervention targets for nutrition-associated neurologic morbidity in Zambia and frame future observational studies to identify complex pathogenic mechanisms involved in asymptomatic and symptomatic DSP development.